Engineered Envelope Glycoprotein Trimers for HIV-1 Vaccine Immunogens

DESCRIPTION (provided by applicant): One major obstacle to the development of an effective HIV-1 vaccine is the difficulty in eliciting a broadly neutralizing antibody response. The envelope glycoprotein (Env) complex, the only HIV-1 target for neutralizing antibodies, exists in distinct conformational states on the cell or virion surface. Different oligomeric forms of Env are thought to reflect pleomorphic interactions of two heptad-repeat (HR) regions in the ectodomain of gp41. Intensive immunogen design efforts have been directed toward the creation of a soluble recombinant Env (gp140) protein that forms the mature trimeric structure found in functional spikes. This proposal grows directly out of our recent determination of the crystal structures of the two states of the C- terminal HR1 region of gp41: one, a trimeric coiled coil and the other, a tetrameric coiled coil. Our preliminary results favor the hypothesis that this structural dimorphism can inflence the stability and specificity of the oligomeric Env complex. We propose to use these insights to engineer and produce stabilized forms of the cleaved HIV-1 gp140 trimer as novel candidate immunogens for the induction of broadly neutralizing antibodies. The Specific Aims of the proposed research are: (1) To create homogeneous preparations of stabilized, cleaved HIV-1 gp140 trimers for immunogenicity studies. We will use mutational analysis to dissect the determinants of each of the two newly identified oligomeric coiled-coil interactions in the gp41 HR1 sequence motif. We will build on Moore's SOS method for making a trimeric, stabilized form of gp140 by selecting and testing the HR1 substitutions identified above that stabilize inter-subunit interactions in gp41. We will also make modifications of gp140 trimers in order to reduce pleomorphism and/or flexibility. (2) To evaluate the immunogenicity of stable, cleaved HIV-1 gp140 trimers in small animals and use the resulting data to improve immunogen design. We will conduct immunogenicity studies in rabbits and guinea-pigs to determine whether the stabilization of the gp41-gp41 interactions affect the ability of HIV-1 gp140 trimers to elicit neutralizing antibodies. We will also evaluate the immunogenicity of trimeric gp140 complexes captured onto nanometer-sized beads as particulate immunogens.

Public health relevance
PUBLIC HEALTH RELEVANCE: The research and public health communities concur that a preventive vaccine is the obvious long-term solution to bring the global HIV-1 epidemic under control (1-4). Unfortunately, this goal has proven elusive and no such vaccine is available. Overcoming this important biomedical problem will require new and imaginative design strategies to bring us closer to the goal of a successful AIDS vaccine. The research and public health communities concur that a preventive vaccine is the obvious long-term solution to bring the global HIV-1 epidemic under control (1-4). Unfortunately, this goal has proven elusive and no such vaccine is available. Overcoming this important biomedical problem will require new and imaginative design strategies to bring us closer to the goal of a successful AIDS vaccine. __SpecificAimsTextDelimiter__ A. Specific Aims One major obstacle to the development of an effective HIV-1 vaccine is the difficulty in eliciting a broadly neutralizing antibody response. The envelope glycoprotein (Env) complex, the only HIV-1 target for neutralizing antibodies, exists in distinct conformational states on the cell or virion surface. Different oligomeric forms of Env are thought to reflect pleomorphic interactions of two heptad-repeat (HR) regions in the ectodomain of gp41. Intensive immunogen design efforts have been directed toward the creation of a soluble recombinant Env (gp140) protein that forms the mature trimeric structure found in functional spikes. This proposal grows directly out of our recent determination of the crystal structures of the two states of the C- terminal HR1 region of gp41: one, a trimeric coiled coil and the other, a tetrameric coiled coil. Our preliminary results favor the hypothesis that this structural dimorphism can inflence the stability and specificity of the oligomeric Env complex. We propose to use these insights to engineer and produce stabilized forms of the cleaved HIV-1 gp140 trimer as novel candidate immunogens for the induction of broadly neutralizing antibodies. The Specific Aims of the proposed research are: (1) To create homogeneous preparations of stabilized, cleaved HIV-1 gp140 trimers for immunogenicity studies. We will use mutational analysis to dissect the determinants of each of the two newly identified oligomeric coiled-coil interactions in the gp41 HR1 sequence motif. We will build on Moore's SOS method for making a trimeric, stabilized form of gp140 by selecting and testing the HR1 substitutions identified above that stabilize inter-subunit interactions in gp41. We will also make modifications of gp140 trimers in order to reduce pleomorphism and/or flexibility. (2) To evaluate the immunogenicity of stable, cleaved HIV-1 gp140 trimers in small animals and use the resulting data to improve immunogen design. We will conduct immunogenicity studies in rabbits and guinea-pigs to determine whether the stabilization of the gp41-gp41 interactions affect the ability of HIV-1 gp140 trimers to elicit neutralizing antibodies. We will also evaluate the immunogenicity of trimeric gp140 complexes captured onto nanometer-sized beads as particulate immunogens. B. Background and Significance B1. The need for an antibody-based HIV-1 vaccine: There is an increasingly urgent need to develop preventive vaccines to curtail the global spread of HIV-1 (1-3). One of the greatest obstacles to the development of an effective HIV-1 vaccine is the difficulty in inducing a broadly neutralizing antibody (NAb) response, particularly at mucosal surfaces (2-4). Presently available immunogens based on various forms of the HIV-1 envelope glycoprotein (Env) have not proven capable of eliciting NAbs of sufficient breadth and titer to counter transmission of primary HIV-1 isolates. Moreover, induction of any mucosal antibodies, let alone broadly active NAbs, by systemic or mucosal HIV-1 vaccines has proven highly problematic (2,3). Indeed, the most advanced HIV-1 vaccine concepts that have been tested in large-scale human trials (Ad5 or MVA vectors, with or without DNA priming) either completely omit Env, or are not intended to induce significant titers of NAbs. Instead, their goal is to induce cell-mediated immune responses that may limit the extent of HIV-1 replication post-transmission (3). While there is some support for this concept from the non-human primate models of HIV-1 infection (3,5), clinical trial of an Ad5 vector in humans (STEP trial) was disappointing in that no protection from infection (and arguably enhancement) was observed, and there was no reduction in plasma viral load in infected vaccinees, compared to controls (6,7). A consensus suggests that an effective HIV-1 vaccine must elicit both broadly reactive NAbs and a robust cellular immune response, to protect from infection and disease as well as to reduce transmission (1-3,8-10). The question remains: how to design immunogens that elicit broad, potent and persistent NAbs? The difficulty lies with lack of information on natural immunity to the virus, the extraordinary sequence diversity of Env and continued viral genetic variation (8-10). We propose that solving the 'Neutralizing Antibody Problem' requires an interplay between structural biology and immunology; the research program outlined in this proposal is, accordingly, based in both areas of vaccine science. B2. HIV-1 Env mediates virus-cell fusion and is a target for NAbs: The gp120 and gp41 Env glycoproteins are the only relevant HIV-1 target for NAbs; Env mediates virus attachment and entry into target cells, a process that can be blocked by NAb binding to neutralizing epitopes on gp120 or gp41 (10,11). NAb-based vaccines thus require one or more forms of the Env protein. Env is